Effects and equity impacts of cannabis policy on tobacco and cannabis co-use in young adults

PROJECT SUMMARY/ABSTRACT
Blunts – cigars with the tobacco filling replaced or mixed with cannabis – present substantial health risks to their
users given exposure to harmful chemicals from combustion and the high addictive potential from nicotine in
the cigar wrap and tobacco. Blunts are predominantly used by young adults (YAs) and groups who go on to
suffer disproportionately from tobacco-attributable death and disease, chiefly people who identify as
Black/African American (B/AA). Therefore, B/AA YAs are at greatest risk for the health effects of blunt use. In
the United States, tobacco policies have become increasingly restrictive while cannabis policies have become
increasingly permissive. In this rapidly changing context, it is important to understand how blunt use is impacted
by both tobacco and cannabis policies. However, no studies have evaluated these impacts. There is a critical
need to understand the impact of evolving cannabis and cigar policies on people who use blunts, particularly
B/AA YAs, to address public health and promote health equity. Aligned with National Institute on Drug Abuse
research priorities (NOSI NOT-DA-22-003), the overall objective of the proposed study is to determine the
impact of policies relevant to blunt use on health equity. Informed by a health equity framework to detect,
understand, and reduce health disparities, I will build upon analyses of national data and focus group data (K99
phase) to construct a hypothetical choice experiment (R00 phase) to predict potential impacts of intersecting
tobacco and cannabis policies on blunt use in B/AA YAs. The first aim is to detect the impact of state cannabis
and tobacco policies relevant to blunt use on B/AA and non-B/AA YAs through secondary analyses of Nielsen
convenience store data and Population Assessment of Tobacco and Health Study data. The second aim is to
understand multi-level determinants of blunt use disparities and policy impacts through focus groups with B/AA
YAs. The third aim is to assess the impact of proposed cannabis and tobacco policies to reduce blunt use among
B/AA YAs through a discrete choice experiment. This study will provide timely evidence on an understudied
pattern of cannabis and tobacco use (blunt use) in a priority population impacted by rapidly-evolving tobacco
and cannabis laws. Results are expected to have substantial positive impact by 1) directly informing policy
interventions to support public health, 2) identifying determinants of health inequities from blunt use, and 3)
introducing unique scientific approaches to a budding field of cannabis regulatory science. A comprehensive
training plan is proposed to ensure the implementation of study aims, with objectives focused on: 1) enhancing
research methods to engage health equity through all phases of research; 2) expanding data analytic skills for
policy evaluation; 3) obtaining experience with experimental methods to inform and evaluate policy attributes;
4) extending knowledge in core substantive areas of cannabis use and policy; and 5) developing leadership and
professional skills relevant to tobacco and cannabis regulatory science.

Public health relevance
PROJECT NARRATIVE In a rapidly changing policy landscape, understanding how blunt use is impacted by both tobacco and cannabis policies may inform state policymaking and evaluate policy effects on health equity. The proposed study harnesses a health equity framework to 1) detect the impact of policies relevant to blunt use on health equity, 2) understand determinants of blunt use disparities and policy impacts, including detecting the unique impact among Black/African American young adults who disproportionately use blunts to smoke cannabis, and 3) test policy approaches to reduce blunt use. Results are expected to have substantial positive impact by directly informing policies to support public health, ultimately minimize health inequities from tobacco/cannabis use, and introducing unique scientific approaches to a budding field of cannabis regulatory science.